Antibacterial Host Defense

The purpose of the project is to find out how microbial molecules, such as bacterial lipopolysaccharides, induce the accumulation of triglycerides (i.e., fat droplets) in macrophages. This process is important for the pathogenesis of the foamy macrophages that are found at sites of infection (especially within granulomas) and in arterial walls (where macrophages contribute substantially to atherosclerosis). In FY 2014 we showed that Toll-like receptor agonists (i.e. bacterial molecules such as lipopolysaccharides) induce cultured macrophages to retain triglyceride in lipid droplets. We defined the 3 molecular mechanisms that participate in this phenomenon. We further showed that an important contributor, previously unexpected, is the pH of the culture medium. By inducing cells to secrete acids that lower the medium pH, both TLR agonists and low oxygen tension promote triglyceride storage and decrease cell metabolism in general. These changes are very similar to those reported in the tissues of organs affected by severe sepsis, and we hope to study this possible connection in more detail. We have continued this project to try to understand how macrophages survive in low pH environments and how they resume normal functioning when their extracellular pH returns to 7.4. We have learned that they do not depend upon exogenous fatty acids or glucose; instead they make new fatty acids and oxidize them. They may be protected by low pH because the electrochemical gradient across the inner mitochondrial membrane increases when the intracellular pH is low. We think the findings may help explain how cells slow specialized functions yet remain alive and can recover -- the essential element of organ hypofunction during sepsis. This work was published in J. Immunology in early 2021.